IU training prog. in molecular physiology and clinical mechanisms of lung disease

DESCRIPTION (provided by applicant): This T-32 Training application is anchored within the Indiana University School of Medicine, the principal School of the Indiana University Purdue University at Indianapolis (lUPUI). The proposed training program in Lung Immunobiology is provided by a multidisciplinary, highly collaborative group of established investigators and highly qualified and dedicated mentors. We have included in the training program classical elements of basic and clinical-translational, research, adding on developing novel technologies. These research skills will enable our trainees to accelerate the advancements in lung research and close the gaps in knowledge that prevented for so many decades the development of phenotypic characterization, effective preventive intervention, and disease- modifying or even curative druts for most patients with lung disease. Being led by Program Director who is a renowned physician scientist and experienced mentor who himself is a minority, and having direct support from an experienced Minority Advisory Board, this application demonstrates our commitment to the development of a successful training program for under-represented and minority scientists. The Program Director will obtain continuous advise and feedback regarding the operation of the Training Grant from several internal and one external committee, composed of leaders in academic medicine If funded, this program will provide the only research training program of pulmonary physicians and scientists in the state of Indiana, which has one of the highest incidence of chronic lung diseases in the country.